Male Access to Sexual Health Services and PrEP

PROJECT SUMMARY
Global HIV prevention efforts have conventionally focused on supporting women and key populations through
treatment as prevention resulting in viral suppression (Undetectable = Untransmittable, U=U). This presents the
opportunity to develop interventions that support HIV prevention in heterosexual men, aged 15-49 years. Since
there are no interventions that address PrEP uptake among HIV seronegative heterosexual men, the scientific
goal of this K43 is to develop and prototype an evidence-based intervention to curb HIV acquisition in South
African men at high risk of HIV acquisition. Behavioral economics (BE) theory posits that contextual and
individual factors influence health behavior. BE will be used to understand these factors associated with pre-
exposure prophylaxis (PrEP) uptake in South African men. Candidate: I am a South African behavioral scientist
with a background in HIV research in HIV endemic communities in South Africa I am committed to improve health
seeking in this population. This K43 will support my training, mentorship, and research towards becoming an
independent investigator. Mentoring: I have assembled a multi-disciplinary team with globally recognized
expertise in their fields, committed to HIV research in South Africa. My primary mentors are Dr. Alison Buttenheim
(U.S. based, behavioral economics intervention design, evidence-based HIV care delivery, mixed methods
research), Dr. Linda-Gail Bekker (S.A.-based, clinical trials, PrEP, research in key populations). My co-
mentorship team includes: Dr. Joseph Daniels (U.S.-based, qualitative research, HIV prevention and treatment),
Dr. Andrew Medina-Marino (S.A.-based, epidemiology, men’s health, implementation science). Training: The
K43 will support mentoring and rigorous training to support me to develop expertise in 1) behavioral economics
intervention design, 2) cohort design and managing clinical trials, 3) mixed methods research design and
analysis. These aims will be supported by mentors who are global leaders in HIV prevention in limited resource
communities. Research: HIV prevalence peaks in South African males (45-49 years) later than their female (35-
39 years) counterparts and males tend to choose younger female sexual partners. Reducing HIV acquisition
among men living in LMICs is central to breaking this cycle of transmission. The specific research aims of this
award are to: 1) investigate the influence of contextual factors on PrEP uptake, 2) describe factors associated
with attrition and sustained PrEP use 3) to use BE to develop and prototype an intervention to support PrEP
uptake among men. This research is nested in the existing mobile clinic services operating in the Klipfontein
district in Cape Town, which was recently awarded a PrEP implementation grant (Bill and Melinda Gates
Foundation, PI Bekker) to assess community-based PrEP uptake. This study will advance NIH science on HIV
prevention in men in high HIV disease burden communities. The evidence will be used to design a BE informed
intervention for a larger clinical trial investigating the impact on reducing HIV acquisition and transmission in
men.

Public health relevance
PROJECT NARRATIVE The global focus on women and key populations has curbed HIV related adverse outcomes for these groups, but men in high disease burden locations continue to remain at high risk of HIV acquisition and onward transmission. Pre-exposure prophylaxis (PrEP) research and interventions have prioritized women and key populations, with notable reductions in HIV acquisition in PrEP users. This study addresses a key gap in HIV prevention for men by assessing 1) factors associated with PrEP uptake, 2) factors associated with sustained PrEP use and attrition, 3) and using behavioral economics to design and prototype an HIV prevention intervention for South African males 15-49 years old in high disease burden communities.